Nutrigenetics of cruciferous vegetable intake and breast cancer prognosis

DESCRIPTION (provided by applicant): My long-term goal is to prevent cancer recurrence and improve survival using nutritional/dietary approaches. Breast cancer is my primary focus. Breast cancer is the most commonly diagnosed female malignancy in the US, leaving approximately 2.4 million cancer survivors facing increased risk of disease recurrence and early death. It is increasingly important to identify modifiable lifestyle factors to improve the disease prognosis. Our hypothesis is that higher cruciferous vegetable intake may reduce risk of recurrence and increase survival among breast cancer patients, depending upon their genetic background. The rationale includes: (1) Cruciferous vegetables are rich sources of isothiocyanates (ITCs), a group of promising anti-cancer agents; (2) Polymorphic genes of key enzymes in the pathway of ITC metabolism may affect the bioavailability of ITCs; (3) ITCs potently inhibit the growth of breast cancer cells in vitro and in vivo; (4) ITCs effectively target both estrogen receptor (ER) positive and negative breast cancer cells; (5) ITCs modulate immune function, and inhibit cancer angiogenesis and metastasis; and (6) ITCs potently induce NAD(P)H:quinone oxidoreductase 1 (NQO1), while polymorphisms of NQO1 resulting in low activity strongly predict poor prognosis in breast cancer patients. Two specific aims are proposed: Aim 1 is to examine the effect of cruciferous vegetable intake on breast cancer recurrence and survival. The interactions with functional polymorphisms of key ITC-metabolizing and -inducible genes will be examined. We will use data and specimens from The Pathways Study, a funded prospective cohort study of breast cancer patients. Aim 2 is to evaluate the effect of ITC- rich broccoli sprout extract (ITC-BSE) on breast tumor cells in early stage breast cancer patients in a neoadjuvant study. Biomarkers including Ki-67, cleaved caspase-3, ER, and NQO1 will be examined and the pre-post changes will be compared between treatment and control group. This pilot intervention trial is the mechanistic investigation for the Aim 1 study; it also helps to identify potential biomarkers for monitoring efficacy of dietary ITCs. The proposed study will be the first to address the interactions between cruciferous vegetable intake and individual genetic background in relation to breast cancer prognosis. Due to the wide availability of cruciferous vegetables and the high diet-change motivation of breast cancer patients, the findings from the study may have a significant impact on the lifestyle of breast cancer survivors.

Public health relevance
Project Narrative In the US, the growing population of breast cancer survivors is facing increased risk of disease recurrence and early death, and is highly motivated to change the diet and/or take supplements to modify the risk. The proposed study will be the first to address whether intake of cruciferous vegetables can reduce the risk of breast cancer recurrence and improve breast cancer survival as well as help to identify the most beneficial patient population based on individual genetic background. Due to the wide availability of cruciferous vegetables and the high diet-change motivation of breast cancer patients, the findings from the study may have a significant impact on the lifestyle of breast cancer survivors. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Breast cancer is the most common female malignancy diagnosed in the US, with over 180,000 new cases annually. It is estimated that there are approximately 2.4 million breast cancer survivors in the US. Although most breast cancer survivors are considered "cancer-free", they are faced with high risk of disease recurrence and early death compared to the general population. With the population of cancer survivors growing, it is increasingly important to identify modifiable lifestyle factors, such as diet, which may have beneficial effects on cancer prognosis. Our hypothesis is that higher cruciferous vegetable intake may reduce risk of recurrence and increase survival among breast cancer patients, depending upon their genetic background. The rationale for the hypothesis is that: 1) dietary isothiocyanates (ITCs), a group of phytochemicals primarily derived from cruciferous vegetables, exert potent anti-cancer activities against breast cancer in animal and cell culture models, and 2) the bioavailability of ITCs in humans may be determined by polymorphic genes of key enzymes in the metabolic pathway. In order to test our hypothesis, two specific aims using two distinct approaches (prospective study and pilot clinical trial) are proposed. Aim 1: To examine the effect of cruciferous vegetable intake on breast cancer recurrence and survival. We will use data and specimens from The Pathways Study, a funded prospective cohort study of breast cancer patients (Kushi, PI), designed specifically to examine the effects of lifestyle and molecular factors on breast cancer prognosis. Detailed data on cruciferous vegetable intake and blood samples are collected prior to treatment. As of May 2010, approximately 2,875 patients have been recruited. The recruitment is ongoing. In order to allow at least 5 years of follow up to evaluate recurrence and survival, we will only include women enrolled before the end of 2010. At least 3,000 patients are expected to be included in the analysis. The following research questions will be addressed: 1a. To determine the associations between cruciferous vegetable intake and breast cancer recurrence and survival, and the modifying effect of polymorphisms of ITC-metabolizing genes on the associations. Specifically, glutathione S-transferase (GST) and N-acetyltransferase (NAT) will be examined, as they catalyze the first and last reaction in the metabolic pathway of ITCs. 1b. To determine the associations between NAD(P)H:quinone oxidoreductase 1 (NQO1) polymorphisms and breast cancer recurrence and survival, and the modifying effect of cruciferous vegetable intake on the associations. Polymorphisms of NQO1 resulting in low activity strongly predict poor prognosis in breast cancer patients, while ITCs potently induce NQO1. Aim 2: In a neoadjuvant study, to evaluate the effect of ITC-rich broccoli sprout extract (ITC-BSE) on breast tumor cells in early stage breast cancer patients. This pilot intervention trial not only serves as a mechanistic investigation for the studies in Aim 1, but also helps identify potential biomarkers for monitoring the efficacy of dietary ITCs. At diagnosis, postmenopausal women with early stage breast cancer (stage I and II) will be recruited at RPCI. Participants will be randomly assigned to receive broccoli sprout extract (containing 200 μmol ITCs) or placebo daily for two weeks immediately prior to surgery. A panel of selected markers will be examined using immunohistochemistry, and the changes between pretreatment biopsy samples and posttreatment surgical excision specimens will be compared between treatment and control group. Levels of urinary ITC metabolites will be measured to monitor study compliance. The effects on the following selected biomarkers will be examined: 2a. To determine whether the intervention alters proliferative and apoptotic markers (Ki-67 and cleaved caspase-3). 2b. To determine whether the intervention down-regulates the expression of ER. 2c. To determine whether the intervention induces NQO1 expression. Impact: Breast cancer survivors are highly motivated to change diet and/or take supplements to improve their prognosis. However, there is little scientific guidance for selection of modifiable factors that may affect cancer outcomes. The proposed study is the first to evaluate the role of cruciferous vegetables in breast cancer recurrence and survival, with genetic background taken into account to identify those who will most benefit from the intervention. With the population of breast cancer survivors growing, this study fills a critical gap, and can provide timely information that could impact a large proportion of breast cancer survivors. Considering the wide availability of cruciferous vegetables in the US, the study could have immediate impact on lifestyles of breast cancer survivors. Most importantly, promising dietary supplements could be developed for high-risk breast cancer patients.